HETEROGENEITY OF APO B LIPOPROTEINS IN IDDM

This study will examine the abnormalities in composition of VLDL and LDL in IDDM patients with normal and high cholesterol levels and compare them to normal healthy non-diabetic subjects. The study will also examine whether a high carbohydrate diet or a high monounsaturated fat diet can be effective in mitigating these abnormalities of lipoproteins in IDDM. The results of this study therefore will have important implications in devising therapeutic strategies to reduce risk of CHD in IDDM patients.